Structural studies of psychedelic activity at the serotonin receptor 5-HT1A

PROJECT SUMMARY
The rise of interest in psychedelic medicine calls for further exploration of the mechanisms underlying the
therapeutic nature of these drugs. Serotonin receptors are well-established regulators of behavioral and
cognitive effects. In particular, the serotonin receptor 5-HT1A is a primary target of antidepressant, anxiolytic,
and antipsychotic medications. 5-HT1A is also a high-affinity target of multiple psychedelic drugs, but its role in
the physiological effects of psychedelics has been overlooked as the serotonin receptor 5-HT2A is suggested
to be the primary mediator of hallucinogenic effects. However, select psychedelics have equivalent or greater
affinity for 5-HT1A over 5-HT2A. This project seeks to determine the unique molecular details of psychedelic
binding and activity at 5-HT1A with structural and functional studies. Structures of a 5-HT1A-G-protein complex
bound to psychedelic and therapeutic drugs will be solved via cryo-electron microscopy, revealing ligand and
transducer binding interactions at near-atomic resolution. This project will also address the lack of receptor-
level information on psychedelic activity with a series of in vitro functional studies. Distinct signaling pathways
have been associated with therapeutic or undesirable effects at other G-protein coupled receptors. As such,
the activity of existing psychedelics at 5-HT1A and 5-HT2A will be characterized across two major signaling
pathways—G-protein and b-arrestin. Additionally, the psychedelic 5-methoxy-dimethyltryptamine (5-MeO-
DMT) is reportedly selective for 5-HT1A over 5-HT2A. This scaffold will be exploited. A series of 5-MeO-DMT
derivatives will be synthesized and tested to identify the pharmacophores conferring selectivity for 5-HT1A over
5-HT2A. This experiment will generate selective compounds useful for delineating the role of 5-HT1A in vivo. In
a parallel set of experiments, 5-HT1A will be mutagenized to identify individual residues that play a key role in
5-HT1A activity and signaling. These experiments will confirm structural observations and identify important
residues outside of 5-HT1A’s ligand binding pocket. The complementary results of structural and functional
experiments will serve as an invaluable resource for future in vivo and drug-design efforts. In summary, the
proposed studies will reveal the structural and chemical determinants of psychedelic activity at 5-HT1A and
generate novel psychedelic compounds with defined activity, which can be used in future studies to delineate
the precise role of 5-HT1A in psychedelic physiology.

Public health relevance
PROJECT NARRATIVE Psychedelics have been proposed as treatments for debilitating illnesses such as depression and substance- abuse disorder, and a number of commercial entities are attempting to develop psychedelic compounds as marketable therapeutics. However, there is a fundamental lack of understanding about the pharmacology underlying the physiological response to psychedelics. This project aims to use basic science to shed light on psychedelic activity by examining the interaction of the serotonin receptor 5-HT1A—a major therapeutic target—with psychedelics in structural and functional studies.